ShEEP Request for a Replacement Confocal Microscope for the Cell Imaging Core Facility

Confocal microscopy is an optical imaging technique that is an essential research tool to determine
structure and localization in cells and tissues in two and three-dimensional space. The San Francisco VA Health
Care System Cell Imaging Core Facility currently has an aged (>15 years old Zeiss LSM510Meta) confocal
fluorescent microscope, which has frequent and recurring malfunctions, is no longer supported by the
manufacturer, and no longer provides publication quality resolution for images. To fulfill the imaging needs of
current VA-funded research, and to provide an excellent imaging resource for basic and clinical scientists for
years to come, we request a state of the art Leica Stellaris 5 fluorescent confocal microscope.
The Leica STELLARIS 5 Spectral Inverted Tandem Scanner Confocal with LIGHTENING Super
Resolution and Tau Sense Lifetime is equipped with many innovative and unique features to provide high-quality
and fast imaging for a broad spectrum of fluorescent probes. This microscope was just released in May 2020
and offers exciting new and key features including 1) a white light tunable supercontinuum laser to excite fluors
over a broad range of wavelengths, 2) high class glycerol-based immersion confocal grade objective lenses with
motorized correction to visualize imaging in thicker tissues, 3) Power HyD S super sensitive detectors that
improve image contrast and quantitation, 4) fast and high confocal resolution over large areas, and 5) a navigator
tool that enables continuous back and forth viewing between an overview image and a targeted area of interest.
A functional and innovative confocal microscope with these exciting new features will attract users to the core
facility. We expect that usage fees from all users will be sufficient for maintenance.
Research projects advancing studies of diseases highly relevant to the Veterans’ community that will be
supported by this equipment include studies focusing on brain diseases, such as traumatic brain injury (TBI),
stroke, and frontotemporal dementia (FTD). Confocal microscopy is required to simultaneously image multiple
brain cells in affected tissues to determine cellular localization and gene expression. Lung transplant studies
will be served by this equipment to image fluorescent telomere-specific peptide nucleic acid probes and natural
killer (NK) cells in lung transplant tissues. Infectious disease research projects related to Neisseria gonorrhoeae,
HIV, and SARS-CoV-2 will be able to utilize this equipment to better understand the pathogenic mechanisms of
infection and persistence. Studies of prostate cancer will also utilize this equipment to characterize prognostic
biomarkers.
We are excited to request the Leica Stellaris 5, a state of the art confocal microscope that will provide
innovative and outstanding images for research studies to advance Veterans’ health. This replacement is much
needed; the current microscope has been not supported by the manufacturer for a few years now and is
frequently non-functional. We anticipate the Leica Stellaris 5 to provide services essential towards
accomplishing VA’s research goals to understand and treat diseases of high importance to the Veteran
population.

Public health relevance
The long-term objectives of this application are to provide an outstanding and innovative high-resolution imaging resource for the current and future Veteran’s Affairs research community, which will lead to advancements in the diagnostics, prognostics, and treatments for diseases and conditions that disproportionately affect Veteran’s health. Current and future funded VA research projects will require and benefit from microscopy services provided by the San Francisco VA Cell Imaging Laboratory Core Facility. The requested Leica Stellaris 5 confocal microscope will service research projects that are advancing studies in several disease areas highly relevant to Veterans, including traumatic brain injury, lung transplant, prostate cancer, infectious disease, dementia, and COVID-19. We request a state of the art confocal microscope to replace severely outdated and obsolete equipment. Our broad goal is to provide an excellent imaging facility with functional, cost-effective, and efficient equipment.